Mobile element derived chromatin looping variability in human populations

Project Summary
Mobile element insertions (MEIs), or transposable elements, have been established to contribute to ongoing
mutagenesis of the human genome, leading to widespread variability and sporadic cases of human disease.
Recent work has begun to illuminate underlying roles through which MEIs affect regulatory processes through
their combined effects on transcription factor binding and 3D chromatin looping. Recent work from our group has
demonstrated the importance of MEIs in establishing chromatin looping variability in driving differential gene
expression. These observations have precipitated development of molecular and computational approaches to
study their impact on human biology, including whole-genome and target-capture strategies leveraging short-
read sequencing technologies. However, these methods fail to accurately capture the entire landscape of MEIs
within the human genome because of their limited ability to identify non-reference polymorphic MEIs. This failure
derives in part from a blind-spot of short-read genome sequencing: because the human genome harbors over 1
million MEIs, unambiguous alignment of short reads is problematic. Given the demonstrated importance of MEIs
to human biology and evolution, it is imperative that novel methods capable of comprehensively mapping their
locations across many human genomes be developed. In this proposal we aim to 1) Quantify the effects of TE
activity on CTCF binding in a human population sample of 51 well-studied individuals using computational meth-
ods, 2) Map invariant and polymorphic LTR13 insertions in the CEU population and investigate their effects on
intraspecies variability in CTCF binding, chromatin looping, and gene regulation, and 3) Directly map
HARVK/LTR13-anchored chromatin loops through enrichment-capture combined with ONT-based chromatin
conformation capture sequencing. We expect completion of these aims to yield the following outcomes: We will:
1) Present the first reliable estimate of the contribution of polymorphic MEIs to CTCF-mediated chromatin looping
variation in a human population. 2) Improve understanding of how fixed and polymorphic MEIs contribute to
population-level variability in regulatory activity, gene expression, and disease risk. 3) Demonstrate causality of
ongoing MEI activity regarding population-level looping variation and differential gene expression. The new meth-
ods proposed here will address the shortcomings of existing short-read sequencing technologies, allowing us to
comprehensively and cost-effectively map target MEIs across a broad population sample, bridging important
gaps in our knowledge of how gene regulatory processes evolve in the human genome.

Public health relevance
Project Narrative This project seeks to understand the impact of polymorphic mobile elements on the changes to the 3D structure of the human genome. Previous work has shown that these elements account for more than 50% of chromatin contacts. Accurate mapping of these elements will improve understanding of how fixed and polymorphic mobile elements contribute to population-level variability in regulatory activity, gene expression, and disease risk.